Low Intensity Focused Ultrasound for Chronic Pain: High Resolution Targeting of The Human Insula

Chronic pain, that is, pain that persists or recurs for 3 months or more, affects 20 % of adults in the United
States and contributes to an annual economic cost of greater than $600 billion and is more prevalent among
Veterans compared to non-Veterans with significantly higher rates of chronic pain in women veterans.
Noninvasive neuromodulation holds promise as a therapeutic approach to treat chronic pain conditions, but
current noninvasive neuromodulation techniques lack spatial specificity and are unable to modulate deep
neural structures. Low-intensity focused ultrasound (LIFU) is a noninvasive method to inhibit cortical and deep
brain regions. LIFU can reach deep brain regions and has spatial specificity. For chronic pain, one promising
brain target for treatment is the insular cortex, a brain structure whose function is linked to pain processing.
The insula is a critical brain region which is activated in the response to painful stimuli and in chronic pain
states, underlying central sensitization(CS) which occurs in chronic pain syndromes. Our recent pilot data in
healthy controls demonstrates that LIFU can target with spatial specificity subregions of the insula; LIFU to the
posterior insula (PI) reduces contact heat evoked potentials as well as temporal summation of pain(TSP) and
conditioned pain modulation (CPM) which are laboratory measures of somatosensory pain processing that are
altered in CS. LIFU can selectively target the insula and its subregions and provides a potentially
transformative method to reduce pain and the processes in chronic pain states that constitute CS which
amplify chronic pain disorders. We will administer inhibitory LIFU to the PI in individuals with chronic back
pain(CBP) with symptoms of widespread pain, a population that demonstrates symptoms of CS. We will inhibit
the PI to determine whether there is a causal role for this brain region in altered processes of CS as measured
by heat pain thresholds, TSP, and CPM all of which are hallmark features of chronic pain syndromes with CS.
As an LIFU control condition we will use sham LIFU with auditory masking to the insula; the sham condition
has been shown to be indistinguishable from active LIFU. We also propose to examine the effects of LIFU to
PI compared to sham on patterns of blood level oxygen dependent (BOLD) activity during evoked thermal pain
and resting state. Specifically, we will examine the effect of LIFU to PI compared to sham on the 1) BOLD
response to thermal stimuli in the Neurologic Pain Signature(NPS)which is a multivariate outcome whose
magnitude predicts clinical pain intensity and 2) resting state functional connectivity during tonic pain in the
Tonic Pain Signature (ToPS) which also predicts clinical pain intensity. Both the NPS and ToPS are sensitive
to and specific for physical pain and have been replicated in studies of chronic pain patients. We hypothesize,
given our pilot data, that inhibitory LIFU to PI will increase pain thresholds, reduce temporal summation and
facilitate conditioned pain modulation. LIFU to PI compared to sham will reduce the magnitude of the NPS
and ToPS. The magnitude of the NPS and ToPS will be positively correlated with pain intensity ratings during
task-based and resting state functional magnetic resonance imaging. Pharmacologic and nonpharmacologic
treatment for chronic pain have limited efficacy. There is a need in the veteran population for safe-effective
treatments for chronic pain. LIFU provides an ability to transiently and selectively inhibit this critical brain area
to determine its causal role in chronic pain which then may lead to improved treatments for chronic pain.

Public health relevance
Chronic pain, that is, pain that persists or recurs for 3 months or more, affects 20 % of adults in the United States and contributes to an annual economic cost of greater than $600 billion and is more prevalent among Veterans compared to non-Veterans with significantly higher rates of chronic pain in women veterans. Using noninvasive techniques to change the function of brain areas that are involved in chronic pain is one approach to developing treatments for chronic pain conditions. A small area of the brain called the insula is activated in chronic pain conditions. This study tests a new noninvasive technique called low intensity focused ultrasound (LIFU) as a way to inhibit the insula and determine whether this causes individuals with chronic pain to have a reduced response to painful stimuli and whether activity in the insula is decreased after LIFU. Results from this study could provide important information on how brain function changes with chronic pain disorders and may lead to improved treatments for chronic pain.